FAMICICLOVIR FOR RECURRENT GENITAL HERPES IN HIV INFECTED PATIENTS

Collect information on clinical activity of recurrent anogenital herpes simplex infections in HIV patients treated with famiciclovir and assess the safety of famiciclovir in HIV patients.